Biostatistics and Bioinformatics

The goal of the Gastrointestinal Biostatistics and Bioinformatics Core (GI-BBC) is to provide wide-ranging, high-quality statistical and bioinformatics support to the GI SPORE. The primary aim of the GI-BBC is to assist GI SPORE investigators in the design, conduct and analysis of laboratory and clinical studies proposed in this SPORE application. The GI-BBC will focus its efforts on assisting both the clinical and laboratory investigators in translating their pre-clinic studies into clinical studies by providing state-of-the-art experimental designs and analyses through statistical consultation and in collaboration with respect to methodology, feasibility, analysis, and reporting of clinical and laboratory studies. In addition, the GI-BBC will serve as an ongoing resource for all GI-SPORE Investigators. The Core will be led by Dr. Klein and staffed with three additional faculty members as co-investigators: Drs. Hao Wang, Rachel Karchin, and Gary Rosner. These GI-BBC faculty members have complementary areas of expertise: Dr. Klein in epidemiology and statistical genetics. Dr. Rosner in biostatistics and clinical trials. Dr. Wang in clinical trials and longitudinal modeling, and Dr. Karchin in computational genetics. Ms. Marianna Zahurak, a biostatistician in the Cancer Center, will assist Drs. Klein, Rosner, and Wang in statistical analyses. Centralization of statistical needs within the GI-BBC core will provide SPORE investigators with open access to a team of statisticians with the skill set necessary to meet the current and future goals of the SPORE in a cost-effective manner. In addition, it will facilitate communication across SPORE projects, aiding the translation of research findings into the clinical setting.

Public health relevance
The goal of the Gastrointestinal Cancer Biostatistics and Bioinformatics Core is to provide comprehensive statistical and informatics support to GI-SPORE investigators. This includes assisting GI-SPORE investigators in the design, conduct and analysis of the laboratory and clinical investigations that will be conducted as part of this overall application.